Enhancing Chimeric Antigen Receptor T Cell Therapies for HematologicMalignancies: Beyond CART 19

OVERALL PROJECT SUMMARY / ABSTRACT
The long-term goals of this renewal P01 are to develop next generation immunotherapy with chimeric antigen
receptor (CAR) T cells and to translate this research into new therapies with curative potential for patients with
blood cancer. The CAR developed at our center was the first cell and gene therapy to ever receive approval from
the FDA, initially for refractory/relapsed pre-B cell acute lymphocytic leukemia (ALL) in 2017 and lymphoma in
2018. However, multiple myeloma (MM), acute myeloid leukemia (AML) and chronic lymphocytic leukemia (CLL)
remain as the major unmet medical need in blood cancers. Our central hypothesis is that therapies with
combination of CAR T cells and advanced forms of human genome editing will enable this powerful therapy to
reach a broader spectrum of patients with blood cancer. We have brought together a cadre of exceptional
investigators from multiple disciplines who have collaborated and published together for many years. Each
disease-focused project will be led by recognized authorities in the field. To achieve our goals, we have three
Projects that build on progress during the previous funding period and will continue to coordinate closely with
essential shared resource cores. In Project 1, we will determine the clinical and immunological impact of treating
patients on two clinical trials: (i) CAR T cells targeting CD19 will be tested with genetic disruption of CD5, CTLA-
4 and TET2 to address CLL and lymphoma, which is lack of sustained effector CAR T function in these patients.
In AML, the central problem in CAR T cell therapy is the lack of a known surface antigen that is present on AML
but lacking from normal hematopoiesis. The goal of Project 2 is to open a wide therapeutic window for AML by
genetically-modifying normal marrow to make it resistant to killing by anti-AML CAR T cells, and delivering potent
anti-leukemic CAR T cells specific for CD45. Engineered HSC that are genetically edited to install a
hematopoietic system facilitating non-toxic therapy with these potent CAR T cells will be developed. In Project
3, the overall hypothesis is that anti-myeloma efficacy will be maximized by (i) testing the efficacy of marrow-
derived CAR T compared to current standard of care blood-derived CAR T (ii) improving persistence of BCMA
CAR T with orthogonally mutated IL-2/IL-2R technology and mRNA/lipid-nanoparticle vaccine technology to
overcome suboptimal persistence and efficacy of current BCMA T cells.
The Scientific and Administrative Cores for this P01 are essential for our progress including provision of project
management for collaboration and biostatistics, clinical safety and monitoring, and fiscal support (Core A), a
GMP facility for manufacture of cells and identification of new binders for CAR targets (Core B), and a state-of-
the-art platform for GLP analysis to provide high dimensional data of the samples generated in all Projects (Core
C). Our renewal application has the potential for paradigm-shifting impact to transform the lessons of CAR T for
ALL into meaningful efficacy against all hematologic malignancies, solid cancers and provides direction for
extending beyond cancer to autoimmune disorders.

Public health relevance
Overall Narrative Our goal is to develop practice changing, next-generation immunotherapies for hematologic malignancies which strike more than 200,000 people every year in the United States. Our approach involves the development of next-generation therapies with chimeric antigen receptor (CAR) T cells, involving innovative combinations of CAR T cells and genetic editing with CRISPR/Cas9 technology and base editing to be tested in several clinical trials. Our team has provided paradigm-shifting impact in B cell malignancies and these projects have the potential to transform therapies for numerous cancers beyond acute leukemia.